Mechanisms of Prion Spread and Neuronal Toxicity

Synaptic dysfunction and neuritic dystrophy are prominent pathologic features of the prion- and
Alzheimer’s disease-affected brain. Ubiquitinated protein inclusions are also commonly observed,
providing strong evidence of impaired proteostatic pathways. Ubiquitination of cell membrane
proteins and clearance through the ESCRT pathway (endosomal sorting complex required for
transport) is critical to maintaining synaptic homeostasis. Here we will deeply investigate the
ESCRT pathway contributions to disrupted synaptic homeostasis in prion disease. In prion-infected mice, we have found markedly reduced ESCRT-0 (an Hrs and STAM1 protein complex)
and an enrichment of ubiquitinated proteins in synaptosomes. Strikingly, depleting neuronal Hrs
in prion-infected mice shortened survival time and accelerated the degeneration of synapses,
biochemically and structurally. Additionally, in a longitudinal study of the prion-infected
hippocampus, we found an upregulation in the synaptic activity response gene, Arc/Arg3.1, and
a chronic elevation in phosphorylated CaMKII and phosphorylated AMPA receptors, suggestive
of enhanced and altered synapse function beginning in early disease. Our long-term goal is to
decipher how prion and amyloid-β oligomers disrupt signaling pathways linked to the cellular prion
protein, inducing proteostatic dysfunction and synaptic degeneration. Using electrophysiology,
correlative light-electron microscopy, and proteomics on uninfected and prion-infected cultured
neurons, we will first determine how Hrs expression impacts synapses, assessing activity, pre-and post-synaptic proteins, structure, and signaling. We will then test how distinct prion
conformers impact the ESCRT pathway and neuronal signaling at glutamatergic synapses.
Finally, we will investigate the contribution of glutamate receptor activity to prion spread and
neurodegeneration. We will directly test how the findings in these genetically manipulated models
compare to human prion-affected brain. These studies are the first to test how neuronal activity
impacts prion dissemination, synaptic degeneration, and disease progression, and outcomes are
expected to provide key insights into the deregulated synaptic signaling that drives neuron loss,
thus revealing new therapeutic targets.

Public health relevance
Prion diseases are rapidly progressive, fatal neurodegenerative disorders caused by prion protein aggregates spreading through the brain and spinal cord. We will use directed and unbiased proteomics experiments to determine how prions trigger synaptic dysfunction and neuronal degeneration in well-characterized, highly reproducible neuronal and animal model systems, as well as patient samples. We expect that the proposed studies will elucidate the signaling pathways that drive synapse loss in prion disease, and uncover new therapeutic targets.